Immunotherapeutic targeting of gangliosides in Ewing Sarcoma

Project Summary
Ewing sarcoma (EWS) is the second most common tumor involving bone in children and young adults and is
fatal in most patients with metastatic or relapsed disease. Patients who survive are left with a lifetime of late
effects from the toxic therapy they receive. There have been no new, successful targeted drugs developed to
treat EWS for nearly forty years, and we have reached the limit on how much we can intensify chemotherapy
treatments. New therapeutic approaches are necessary to prevent relapse and cure more patients.
Immunotherapy has altered the treatment landscape for many adult solid tumors but has not yet mediated
substantial benefit for children with EWS. Chimeric antigen receptor (CAR) T cells have revolutionized the
treatment of children with relapsed leukemia and lymphoma. Recently, we found that CAR T cells targeting GD2,
a sugar expressed on the surface of many pediatric cancers, are active in children with incurable brain tumors.
This proposal focuses on applying GD2 CAR T cells to EWS. Because GD2 is heterogeneously expressed on
EWS, we will explore multiple mechanisms to effectively apply CAR T cells in this disease: 1) targeting a closely
related ganglioside that is highly expressed when GD2 is low and 2) utilizing epigenetic inhibitors to significantly
increase GD2, making CAR T cells better able to recognize tumor cells. In Aim 1, we will define the expression
of gangliosides and their related synthase enzymes on patient tissues and test CARs against an alternative
ganglioside. In Aim 2, we will utilize epigenetic inhibitors to increase GD2 on EWS tumors in vitro and in vivo. In
Aim 3, we will test combinatorial approaches of CAR T cells and epigenetic inhibitors. Successful completion of
these studies will result in new therapeutic options for children with Ewing sarcoma.

Public health relevance
Project Narrative: Ewing sarcoma is the second most common bone tumor occurring in children, but there have been no improvements in treatments or survival rates for more than a decade for patients with advanced disease. While immunotherapy with chimeric antigen receptor (CAR) T cells has mediated major advances in pediatric leukemia, it has not yet proven effective in Ewing sarcoma. We will explore approaches to apply CAR T cells targeting the validated target GD2 and other ganglioside targets to treat this highly recalcitrant pediatric cancer.